Multiscale hydrogel biomaterials-enabled 3D modeling of cancer drug resistance

Project Summary/Abstract
Developing new anticancer drugs has been very slow and costly. A major reason is that the commonly used
2D cancer cells and animal models for drug discovery today are very different from the 3D tumors in human
patients. Lately, 3D tumor models have been made by suspending tumor cells in medium to form multicellular
spheroids/organoids, growing the cells in hydrogels/scaffolds, and incorporating blood vessels. However, little
has been done to build 3D vascularized tumor models for recapitulating the drug resistance in patient tumors.
We recently developed a novel multiscale hydrogel biomaterials-based bottom-up strategy to control the
formation of the two distinct tissue domains in tumors - a 3D vascular network and an avascular/intervascular
tumor cell-containing region, for studying cancer drug resistance. This is achieved by producing 3D avascular
micro-tumors (µtumors) first and using them as the building blocks for assembling with endothelial cells (ECs)
under dynamic perfusion culture, to form 3D vascularized tumors with a complex 3D vascular network that
mimics the vascular-intervascular organization of in vivo tumors. Importantly, our data show quantitatively for
the first time that, the 3D vascularized tumors are much more drug resistant than 3D avascular µtumors,
indicating tumor blood vessels not only transport nutrients/oxygen but also enhance cancer drug resistance.
However, no 3D vascularized tumor was built in vitro with cells differentiated from cancer stem cells (CSCs)
for drug discovery, although the rare CSCs have been posited to possess the exclusive ability of tumorigenesis
and be responsible for the many failures of cancer chemotherapy due to their high drug resistance. Moreover,
no CSCs isolated with contemporary methods are shown to differentiate into a type of cells that are not in
tumors. This cross-tissue multilineage differentiation is a key property of stem cells (e.g., adipose-derived stem
cells can differentiate into osteoblasts that are absent in fat). Thus, a method for isolating true CSCs is in need.
We recently developed a novel core-shell hydrogel biomaterials-based approach for isolating CSCs by
culturing one (1) single cancer cell (from a cell line) in the nanoliter hydrogel core of microcapsules that mimic
pre-hatching embryos, where totipotent-pluripotent stem cells are cultured in human body. Importantly, the
isolated CSCs are capable of endothelial, cardiac, neural, and osteogenic differentiations and highly tumorigenic,
metastatic, and drug resistant, indicating the cells isolated with our bioinspired 1-cell culture are truly CSCs.
In this project, we propose to further develop the novel bioinspired approach for isolating CSCs from breast
tumors of human patients. In view of the highly drug resistant nature of the CSCs isolated with our bioinspired
1-cell culture and their ability of differentiating into ECs in vivo that may reduce patient survival, we further
propose to use the CSC-derived ECs and cancer cells for building 3D vascularized tumors, to better model the
drug resistance in patient tumors than existing 3D vascularized tumors made using non-CSC cancer cells and
non-CSC (and often non-cancer-related) ECs (e.g., human umbilical vein endothelial cells known as HUVECs).

Public health relevance
Project Narrative-Relevance to Public Health We propose to develop a novel bioinspired 1-cell culture technology for isolating cancer stem cells (CSCs) that are capable of cross-tissue multilineage differentiation from cancer patients’ tumors, and to further utilize the CSCs for engineering 3D vascularized tumors using an innovative bottom-up strategy. This project may lay the foundation for creating novel high-fidelity CSC-based 3D tumor models to accelerate cancer drug discovery and for developing effective CSC-targeted therapies to combat cancer drug resistance-induced cancer recurrence and metastasis that are the main causes of mortality in cancer patients.